Complex genetic encoding of experience by NPAS4 resulting in a sophisticated reorganization of inhibition.

Project Abstract
When a mouse explores an enriched environment the pyramidal neurons in the CA1 region of its hippocampus
receive excitatory inputs and fire action potentials to encode information about their complex environment. This
experience-induced activity results in the expression of the activity dependent transcription factor NPAS4 via de
novo transcription and translation, as well as local dendritic translation of preexisting NPAS4 mRNA. This
enriched environment induced NPAS4 produces changes in gene expression resulting in a sophisticated
reorganization of inhibition across the somato-dendritic axis, with an increase in the number CCK Basket Cell
synapses onto the somatic region and a decrease in the number of inhibitory synapses on the radiatum dendrites
of NPAS4 expressing cells. This proposal describes experiments designed to determine 1) the genetic identity
of the radiatum targeting interneuron type which loses synapses onto NPAS4 expressing cells, and 2) the
necessity of dendritic translation of NPAS4 in this sophisticated reorganization. These experiments will provide
insight into fundamental biology underlying the complex regulation of inhibitory networks and the role that
experience and activity dependent dendritic translation play in this process. Given the known relationships
between dysregulation of inhibition, dendritic translation, and a variety of neurological disorders with experience
dependent symptomology, this work will aid our understanding of neurological function and dysfunction.

Public health relevance
Project Narrative NPAS4 is an activity dependent transcription factor that is expressed in mouse hippocampal CA1 pyramidal neurons during exposure to an enriched environment via both de novo transcription and local dendritic translation. This experience dependent expression results in a sophisticated reorganization of inhibition onto NPAS4 expressing neurons, substantially changing the organization of the microcircuit. This project aims to determine both the circuit details and the necessity of the dendritic translation of NPAS4 in this phenomenon, providing insight into a remarkable form of environmentally driven circuit plasticity.